Ensemble Activity in Rat Striatum During Habit Learning

DESCRIPTION (provided by applicant): The basal ganglia are centrally involved in the etiology of neurologic disorders such as Parkinson's disease and in the motor and cognitive functions that are affected in these disorders. The basal ganglia are also implicated in neuropsychiatric disorders, such as obsessive-compulsive disorder, that are closely related to and often co-morbid with anxiety disorders and depression. It is of great importance to the field of mental health to understand how the basal ganglia could contribute to such a range of brain disorders. The basal ganglia are also central to habit formation and to the neural mechanisms underlying addictive behavior. We propose a series of coordinated studies to test specific hypotheses about cognitive and action-directed functions of the basal ganglia in such habitual and repetitive behaviors. We have developed a behavioral model that allows rats to initiate voluntary movements, and to make a "decision" whether to execute one or another movement pattern in order to receive reward. Our preliminary data indicate large-scale plasticity in striatal neuronal firing patterns during procedural learning. These patterns occur as a shift occurs behaviorally from "exploration" to "exploitation" as a result of learning. We now propose to record neuronal activity in the striatum, with multi-electrode chronic recording methods, as rats perform reward-based tasks that will vary in complexity and in task parameters related to reward anticipation in order to analyze specific properties of striatal plasticity. We propose to record both spike activity and local field potential activity and to approach data analysis focusing on three specific hypotheses. Through these studies, we aim to elucidate functional properties of basal ganglia activity during learning and the plasticity of this activity during learning. Together, the proposed studies will help to clarify the function of cortico-basal ganglia loops implicated in neurologic and neuropsychiatric disorders. Understanding how patterns of activity are acquired in these brain circuits is directly relevant to understanding how abnormal patterns of activity could be laid down. Such analyses of neuroplasticity in the basal ganglia are thus relevant to work on a range of human disorders, including Parkinson's disease, Huntington's disease, Tourette syndrome and related OC- spectrum disorders. We thus believe that the proposed work is important for the mission of the NIMH, which is to understand, prevent and cure mental illness.